Understanding the role of catheter-associated protein deposition in the development of CAUTI

PROJECT SUMMARY: Modern healthcare has implemented medical devices to help and improve the life quality
of people with chronic and lifestyle diseases. Paradoxically, although these devices are successful in achieving
their purpose, they make the patient susceptible to infections. Urinary catheters are among the most widely used
medical devices, and currently, catheter-associated urinary tract infections (CAUTI) are the most common
healthcare-associated infection (HAI) worldwide, accounting for 40% of all HAIs. In addition, the treatment and
control of CAUTI is becoming increasingly challenging due to the rise of antibiotic-resistant pathogens. Critically,
CAUTIs are very different from uncomplicated urinary tract infections (UTIs), exhibiting unique clinical and
pathological manifestations, as well as causative organisms. For example, in uncomplicated UTI, E. coli accounts
for >95% of the causative agent, whereas in CAUTI, urinary catheterization allows pathogens such as
Enterococcus spp., Staphylococcus aureus, Candida spp., Proteus mirabilis, Pseudomonas aeruginosa, and
Acinetobacter baumanii to colonize the bladder, something that otherwise would not occur. Given that the
frequency of catheter usage is only expected to increase due to both an aging population and medical advances,
it is imperative to understand the pathophysiology of CAUTI if we are to develop ways to treat and/or prevent it.
Recent work has found that urinary catheterization elicits bladder inflammation and mechanically disrupts the
host defenses, compromising the host for microbial colonization. Further findings in mice and humans have
shown that fibrinogen (Fg) is released and accumulated in the bladder to heal the damaged tissue. Fg is also
deposited on catheters, coating them and forming a platform for colonization by CAUTI-associated pathogens.
It was found that Fg levels modulate outcome of the infection and, in the absence of Fg, E. faecalis is unable to
stick to the catheter and colonize the bladder. On the other hand, high Fg levels enhance enterococcal bladder
and catheter colonization. This suggests that protein deposition on urinary catheters is a key factor for microbial
infection. This proposal tests the hypothesis that by controlling the amount of protein deposition on the surface
using a novel liquid surface coating, we will be able to control the rate and extent of uropathogen biofilm
formation, urinary tract colonization, and systemic dissemination, as well as the inflammation response. Through
a combination of material modification, proteomics, histological, and immunological approaches with a mouse
model of CAUTI, we will: 1) develop liquid-infused catheters that control protein deposition; 2) assess their
contribution in reducing protein deposition and biofilm formation in vitro; and 3) characterize in vivo how protein
deposition modulation affects biofilm formation, the outcome of infection, and inflammation. Understanding the
role of protein deposition in promoting pathogen-material-host interactions will provide new perspective in the
establishment and progression of CAUTI, generating key insights into the development of alternative treatments
that do not contribute to microbial resistance.

Public health relevance
Project Narrative Urinary catheterization is one of the most common healthcare-related procedures; however, placement of a catheter is known to predispose patients to the development of catheter-associated urinary tract infections. Bladder inflammation is induced upon catheterization and changing the bladder environment allowing a diverse group of pathogens to infect. Fibrinogen, a proinflammatory protein, is released in the bladder and deposited onto the catheter surface, becoming a key platform for microbial colonization. This project focuses on understanding how modulation of protein deposition on the catheter by using a liquid surface coating may affect microbial colonization, biofilm formation, and systemic dissemination, as well as the inflammation response. This approach will offer new insights to inform the development of new clinical treatments that will continue to remain effective long-term.